Administrative and Field Coordination Core

PROJECT SUMMARY / ABSTRACT (Administrative and Field Coordination Core)
To maximize the cohesiveness and impacts of the Precision Cardiovascular Disease Phenotyping and
Pathophysiological Pathways in the CARRS cohort (Precision-CARRS), the Administrative and Field
Coordination (AFC) Core will provide scientific and operational governance (Aim 1); field and laboratory oversight
(Aim 2); and communication services (Aim 3) to support this multi-site Program Project Grant (PPG). The AFC
Core will build on ten years of productive collaboration and seamless coordination between Emory University and
its partner institutions in India to conduct cross-national scientific discovery. The Core will be based at Emory and
the Centre for Chronic Disease Control (CCDC). The AFC Core-Emory will leverage existing administrative
infrastructure, the multiple Principal Investigators, Project Leads, and the Data Management and Analysis Core
leadership team. The AFC Core-Emory will oversee governance and communication functions. The AFC Core-
CCDC is comprised of the CVD Phenotyping Core, Delhi and Chennai Site Leads, and field and laboratory
leaders. The AFC Core-CCDC will oversee field data collection and laboratory quality oversight processes,
drawing on ten years of experience, local knowledge, partnerships with communities, and connections with local
and national government. The AFC Core will establish a Steering Committee to facilitate cohesion and linkage
across the three Cores and four Projects. To provide effective governance (Aim 1), the AFC Core will house an
Executive Committee comprised of established scientists with a strong track-record of collaboration who co-
developed the PPG’s vision and organizational structure. The Core has recruited an illustrious Internal Advisory
Group, and laid out plans for an External Advisory Group to obtain strategic guidance and raise the visibility of
Precision-CARRS. The AFC Core will augment previously-developed transparent administrative policies and
processes, including regular reporting mechanisms to ensure PPG goals are being met. Policies and processes
are intended to stimulate efficiency and cohesiveness across the PPG. To support quality assurance and control
for all data collection, handling, and laboratory methods (Aim 2), the AFC Core houses the Field Operations and
Laboratory Committee which is comprised of investigators with expertise and experience in managing the
CARRS Cohort. This group will update and operationalize manuals of operation, training, monitoring, and
reporting to include precision measures that will be collected in the coming five years of the PPG. To promote
effective internal communication, dissemination, and grow collaborations and impact (Aim 3), the AFC Core will
expand the existing Publication, Presentation, and Ancillary Studies Committee. The AFC Core will also establish
new channels of interaction, tracking, and reporting. Through its mix of structures, activities and personnel, the
AFC Core is poised to support this PPG’s cross-cutting goals, scientific impacts, and visibility.